An adoption study of the development of early substance use: the joint roles of genetic influences, prenatal risk, rearing environment, and pubertal maturation

The project summary has not changed from the original application.

Public health relevance
The narrative has not changed from the original application.